The University of Miami AIDS Research Center on Mental Health and HIV/AIDS - Center for HIV & Research in Mental Health (CHARM)Research Core - EIS

PROJECT SUMMARY: EQUITABLE IMPLEMENTATION SCIENCE (EIS) CORE (E)
Based on CHARM strategic growth, significant local and regional investigator need, the National Ending
the HIV Epidemic (EHE) Plan and National HIV/AIDS Strategy, and the importance of equitable implementation
science (EIS) in S. Florida, US South, and the US generally, we propose a new EIS Core in CHARM as part of
our transition from a Developmental to a Full Center. The US HIV epidemic is regionally concentrated in the
US South, with Miami-Dade County (MDC) a leading HIV epicenter and priority region of the EHE plan. Within
MDC, HIV disparities that reflect those across the US and in the South (e.g., race/ethnicity, sexual identity, and
urban vs. rural) are prominent. Given the regional and demographic HIV disparities, there is an urgent need for
equity-focused implementation practice, research, and expertise to end our local, high priority epidemic.
Numerous evidence-based interventions (EBIs) have demonstrated efficacy in addressing HIV disparities in
MDC and populations who experience health disparities in the US South, but lack of EBI adoption,
implementation, and sustainment in community and clinical settings impede EHE progress. Relatedly,
investigators and community collaborators require expertise in equitable implementation practice and research
to fuel implementation efforts. Without an explicit focus on equitably scaling up and disseminating EBIs,
disparities will worsen. As such, EIS is key to achieving the EHE goals in MDC, the US South, and the US. The
overarching goal of the newly proposed Equitable Implementation Science (EIS) Core is to equitably
implement and disseminate EBIs to reach communities who could benefit the most. More specifically, the
Specific Aims for the EIS Core are as follows: 1. To serve as a regional and national resource for early career
and established investigators new to EIS devoted to the study of HIV, mental health and community engaged
research; 2. To support HIV and mental health scientists in developing implementation science projects (e.g., K
or R-level NIH grants or a CHARM pilot application) via consultations; and 3. To create pathways to
stakeholder-engaged implementation research and practice. Accomplishing these Aims will involve key
activities including but not limited to an annual EIS symposium and boutique mentoring program, EIS
workshops and seminars, EIS consultation services from local and national experts, and partnering with the
Dev Core for Program Planning Micro-Grants to facilitate building trusted relationships between investigators
and stakeholders to support locally relevant EIS research. The EIS Director and Co-Directors have expertise
and NIH funding in EIS. Developing an infrastructure at the University of Miami to support EIS is critical to
achieving EHE goals and developing a cadre of EIS scientists who can support the development of future EIS
research at UM, in our region, and nationally. Adding the EIS Core to CHARM will contribute new key activities
that are synergistic with the other Cores. The EIS Core will provide consultations, training, and mentoring that
are key to EIS practice and research that can facilitate equitably Ending the HIV Epidemic in MDC and beyond.

Public health relevance
Project Narrative for Other Components Please see Overall Component for Project Narrative. PAR-20-308 Guidelines Project Narrative: Do not complete. Note: ASSIST screens will show an asterisk for this attachment indicating it is required. However, eRA systems only enforce this requirement in the Overall component and applications will not receive an error if omitted in other components. SF424 Guidelines Overall Component: The "Project Narrative" attachment is required. Other Components: Refer to the specific FOA to determine whether the "Project Narrative" attachment is required for any Other Components. Note: The form may show ‘*’ indicating it is a required field, but it is only required for the Overall Component and the ‘*’ can be ignored for Other Components.